Rewiring networks for a pathogenic lifestyle

Project Summary
Vibrio cholerae causes the severe diarrheal disease cholera that is endemic in much of Asia, Africa, and South
America, and has recently reemerged in Haiti, Syria, and Ukraine. The species is highly diverse, although only
O1 or O139 serogroup strains cause epidemic disease. However, increasing sporadic disease has been
reported globally, and is caused by strains belonging to non-O1/non-O139 serogroups that present a public
health threat both in developed and industrialized nations, including the United States. Unlike pathogenic O1
and O139 strains, the vast majority of pathogenic non-O1/non-O139 strains do not carry the well characterized
virulence factors for colonization (TCP) and toxin production (CT), and the virulence mechanisms used by these
strains are not well understood. Our study of pathogenic non-O1/non-O139 serogroup strains began with
genomic sequencing of the clinically isolated O39 serogroup strain, AM-19226, which revealed a Type Three
Secretion System (T3SS) that is conserved among other V. cholerae isolates. Like TCP and CT, the T3SS is
acquired by horizontal gene transfer (HGT), and integrated into the ancestral chromosome. Our subsequent
experiments identified two membrane localized transcriptional activators (MLTAs) encoded within the T3SS
genomic pathogenicity island (PAI), which are essential for T3SS function in vivo and in vitro. We also found
that ToxR, an ancestral MLTA required for TCP and CT expression, is important for T3SS regulation. ToxR is
encoded by all strains of V. cholerae where it regulates core chromosomal functions, and is well-studied as an
MLTA that cross-regulates PAI and ancestral gene expression. Interestingly, we found that the T3SS encoded
MLTAs influence ancestral gene expression and phenotypes such as motility and biofilm formation. We
hypothesize that in order to survive in aquatic environments and also cause disease, T3SS-positive V. cholerae
must integrate virulence gene regulation with transcriptional circuits outside of the PAI, leveraging the activities
of both ancestral and newly acquired, PAI encoded transcriptional regulatory factors. We propose to use
complementary genetic and biochemical approaches to identify and characterize the mechanisms used by T3SS
PAIs to coordinate motility, biofilm formation, and T3SS gene expression in response to environmental cues.
Initial studies will define the regulons for T3SS MLTAs, and the conditions promoting regulation. We will
investigate protein-protein interactions and MLTA transcriptional domain sequence specificity. Initial studies will
focus on VttRA as the protein at the top of the regulatory hierarchy. Our overall goal is to discover how PAI
encoded MLTA activity regulates virulence phenotypes and ancestral physiological traits that are necessary to
maintain dual lifestyles of newly evolved pathogens.

Public health relevance
Project Narrative Cholera is caused by the water-borne pathogen, Vibrio cholerae, which is endemic in many developing nations. However, disruptions of civil infrastructure due to war and increased environmental crises resulting form global warming have expanded the disease burden globally. V. cholerae strains are genotypically and phenotypically diverse, and can become pathogenic when environmental bacteria acquire virulence factors. We now know that pathogenesis can be mediated by more than one mechanism. Our proposal seeks to provide a detailed understanding of how virulence gene regulation is coordinated with the expression of basic bacterial traits and processes necessary for survival in both aquatic and mammalian environments.